Administrative Core

The Administrative Core will coordinate and facilitate all activities within the proposed program project. This will
include responsibility for the overall organization, management, and utilization of institutional resources.
The Administrative Core will pursue the following Aims:
1. Provide oversight and consultation to each of the Research Projects and Scientific Cores to ensure that
scientific objectives are met and that there is optimal interaction and utilization of resources. The
Administrative Core will monitor and assist each group so that their goals are achieved and emergent
problems are expeditiously addressed.
2. Provide fiscal management and ensure cost-effective utilization of program project resources.
3. Promote the communication of the research team and dissemination of the program project research and
technology, and organize the presentation and publication of data. This aim also will ensure data sharing,
protection of intellectual property, and long-term data storage.